Utilizing mixed methods to understand social determinants of successful disease management among populations with comorbid cardiometabolic syndrome and anxiety disorder

Cardiometabolic and mental health conditions are highly prevalent and complicate management of each other
when they co-occur, leading to greater disability and healthcare costs. Such multi-comorbidity becomes even
more challenging when it intersects with racial inequities and social determinants of health culminating in
amplified risk of adverse outcomes. Successful disease management that works at the intersection of the
individual and the community must be implemented to mitigate disparities and optimal treatment must address
aspects of both cardiometabolic and mental health disorders in a culturally relevant intervention. Evidence based
interventions have not been demonstrated to be culturally relevant for resource poor minority populations. The
community perspective is likely missing in the overall care management of comorbid conditions. Scientific study
must include minorities both in the collection of data and also in the identification of community identified
variables important in successful management of comorbid conditions. Subsequently, positioning these variables
in community-generated conceptual models and then testable computer models will help to identify and highlight
key points for development of culturally relevant intervention strategies. The K01 candidate proposes a parallel,
integrated dynamic process of understanding community perspectives, analyzing risk factors and determinants,
and building and testing computer models that explain disparities and predict outcomes. Connecting the dots
between epidemiologic research and computer modeling through systems science in a community based
participatory framework will allow for the development of accurate replicable models of health disparities that are
co-built by community voices and population scientists.
.

Public health relevance
Project Narrative Social determinants of health influence the progression of Cardiometabolic syndrome (CMetS) disease among individuals with comorbid mental health challenges. Integrated care approaches that address the unique challenges of people with both mental health disorders and CMetS in a culturally relevant manner will likely reduce adverse health outcomes and increase effective disease management. The proposed research will examine the influence of social determinants on mental health and cardiometabolic syndrome risk factor measures among individuals with co-morbid mental health challenges and cardiometabolic syndrome.